Generation and Characterization of Nanobodies Against beta-Amyloid

? DESCRIPTION (provided by applicant): Alzheimer's disease (AD) is the most common dementia in the elderly and imposes a tremendous burden to patients' families and the society both financially and emotionally. Currently, there is no effective treatment available to cure the disease. Pathologically, AD is characterized by the presence of extracellular β-amyloid (Aβ) plaques and intracellular tau-neurofibrillary tangles in selected brain regions including cerebral cortex and hippocampus. Multiple strategies targeting on Aβ generation and clearance are being pursued vigorously in an effort to reduce Aβ levels and Aβ- induced synaptic and neuronal toxicity. However, these attempts, including those using anti-Aβ immunotherapies, have not led to any FDA-approved drugs to treat AD, mainly due to toxic side effects and lack of efficacy. Despite these failures, anti-Aβ-based immunotherapies have made progress. Crenezumab, a humanized monoclonal antibody targeting both monomeric and oligomeric forms of Aβ by Genentech/Roche, inhibits Aβ aggregation and promotes Aβ disaggregation. Although it missed its primary endpoints in a lately completed Phase II clinical trial, crenezumab treatment in people with mild-to-moderate AD showed a trend toward slowing cognitive decline. Most recently, Biogen Idec has announced positive results from a Phase 1b clinical trial on its pipeline drug candidate aducanumab, a human monoclonal antibody that binds aggregated forms of Aβ with high affinity, and plans to carry out a phase III study. Therefore, anti- Aβ immunotherapies are highly promising and improved anti-Aβ therapeutic reagents can help bring such therapies into clinic. The purpose of this proposed project is to generate an advanced nano-antibody for reducing β-amyloid (Aβ) levels and preventing Aβ plaque formation in AD. Nan- antibody (nAb) is a distinctive type of antibody fragment derived from camelid heavy-chain only antibody (HCAb). As a therapeutic candidate, nAb holds many superior properties that may enable some key improvement of current anti-Aβ reagents to help them succeed in clinical trials. In this proposal, we will develop engineered nano-antibodies that will bind Aβ and target it for degradation. We will test the efficacy of such anti-Aβ reagents in cell and mouse models of Alzheimer's disease. We expect that this engineered anti-Aβ nAbs to have higher Aβ binding affinity and greater Aβ reduction efficiency, but less toxic side effects compared to conventional antibodies.

Public health relevance
PUBLIC HEALTH RELEVANCE: Targeting β-amyloid peptide, in its monomer form or aggregated form, has the potential of slowing the progression of Alzheimer's disease. We propose to develop β-amyloid peptide targeting reagents by combining the specificity of novel nano-antibodies (or nanobodies) and cellular degradation signals. The work in this proposal can lay a foundation for further development of such reagents for clinical use.